A mixed-methods, multi-informant study of childhood suicide ideation to improve risk assessment

Abstract
Despite increases in suicides among children, we have no available developmentally and culturally informed
measures of childhood suicide ideation (SI) to inform risk assessment. In addition, there is little information
about how to integrate caregiver reports into assessment of child SI subtypes (based on frequency) and
pathways of suicide risk (based on thematic analysis) among adolescents. A recent study on the severity of SI,
revealed that the most common form of SI among children who had attempted suicide was nonspecific active
SI (without plan, method, or intent). In the absence of a plan, a method, or intent as markers of risk,
assessments may need an approach that focuses on expressions of distress preceding the SI or attempt,
which may be more easily reported by children and detected by caregivers. Body mapping is a “ground-zero”
assessment of expressions of distress that is low in cultural bias and can complement data from verbal reports.
The overall goal of this R01 is to characterize childhood SI and expressions of distress – as assessed by child
and caregiver report – to improve prediction of SI severity and suicide attempts among ethnoracially diverse
children. In consultation with a Community Advisory Board of youth, caregivers, and health workers, we will
conduct a mixed methods study of a diverse sample of 150 children, ages 8-12, with recent SI or SA, and their
caregivers, recruited from emergency departments in New York City and Austin, Texas. Dyads will be
interviewed within two weeks of the child’s SI or attempt, and three and six months later. This project aims: 1)
To identify profiles of SI among ethnoracially diverse children using mixed methods; 2) to test how child SI
profiles predict SI severity trajectories over time; and 3) To test whether child SI profiles show differences in
expressions of distress, as reported by children and caregivers. This project aligns with the NIMH mission of
designing culturally and developmentally informed suicide risk assessments for children. Our findings will
reveal profiles of SI and expressions of distress that children display when they are thinking about suicide or
just before they attempt suicide. The combination of verbal and nonverbal methods, quantitative and qualitative
approaches, and caregiver and child reports overcome limitations of traditional assessments that are mostly
based on verbal responses to a few questions about the presence or absence of suicide ideation or attempts.

Public health relevance
Project Narrative/Relevance Statement This proposal aims to identify profiles of suicide ideation and expressions of distress in children, 8-12 years old, using mixed methods and a multi-informant approach. Findings will provide information that can be used to inform developmentally and culturally meaningful assessments of suicide risk with children and their caregivers.